C0-Overall: Fetal Ethanol-induced behavior deficits: Mechanisms, diagnosis and Intervention

NMARC is a NIAAA-designated Specialized Alcohol Research P50 Center comprised of teams of preclinical and
clinical scientists with a history of collaborative research interactions, whose expertise and contributions have
synergized the center’s research environment and is facilitating progress towards the achievement of NMARC’s
three strategic objectives. These objectives are to: 1) Advance our understanding of how prenatal alcohol
exposure (PAE) affects basic neurobiological mechanisms resulting in functional brain damage, which can lead
to life-long adverse neurobehavioral consequences. 2) Develop more effective approaches for the diagnosis of
individuals with FASD by establishing more sensitive and clinically reliable biomarkers of PAE that are detectable
earlier in life, are prognostic of functional brain damage, and could predict long-lasting neurobehavioral
consequences in patients with FASD. 3) Develop interventions more effective for PAE-related behavioral deficits.
Better interventions may require combinations of neurobehavioral, educational and/or pharmacotherapeutic
approaches to ameliorate the often subtle, but long-lasting impact of PAE. NMARC’s prevailing philosophy is
that a research center organized to maximize the coordination, communication and synergistic integration across
multiple lines of preclinical and clinical investigation provides the best long-term prospect of achieving significant
progress towards the dual clinical goals of better diagnosis and interventions that are more effective for patients
with FASD. NMARC’s specific aims as an integrated whole during the P50 Phase III will continue to be to: 1)
Accelerate progress on each on NMARC’s three strategic objectives. 2) Catalyze the expansion of NMARC’s
research capacity and capabilities. 3) Enhance our ability to disseminate knowledge about FASD through
seminars, symposia and community outreach activities. 4) Increase the number of undergraduate and graduate
students, fellows and residents training in the FASD research field. This competing renewal contains three
preclinical and one clinical research components, each consisting of teams of investigators whose projects
address one or more of NMARC’s three strategic objectives. Three core components support the research
program: 1) A Pilot Project Core of two two-year projects involving faculty investigators new to FASD research.
2) A Scientific Core supporting production of experimental offspring for preclinical projects and recruitment of
human subjects for the clinical project, as well as data management and statistical support for all NMARC-
affiliated projects. 3) An Administrative Core providing scientific and administrative leadership for the entire
NMARC, along with administrative support and budgetary oversight of all NMARC-related activities. The
Administrative Core and a Steering Committee are also responsible for ensuring progress towards achieving the
Specific Aims of the Center as a whole. Assessment of NMARC’s progress towards the achievement of these
aims and the strategic objectives is the responsibility of the Steering Committee, working in conjunction with our
external Program Advisory Committee comprised of five renowned alcohol research investigators.

Public health relevance
PROJECT NARRATIVE - OVERALL Alcohol consumption during pregnancy increases the risk of causing functional brain damage in the fetus that can lead to life-long adverse neurobehavioral consequences. Except in more severe cases, many children affected by prenatal alcohol exposure are difficult to identify, particularly early in life when interventional approaches may have the greatest positive impact. The New Mexico Alcohol Research Center’s objectives are to advance our understanding of how prenatal alcohol exposure causes functional brain damage and use this information to develop better procedures for the diagnosis and treatment of prenatal alcohol effects earlier in life.